Molecular basis for Herpesvirus saimiri oncogenicity

DESCRIPTION (provided by applicant): To endure in hosts through their ability to establish a life-long persistent infection often associated with pathogenesis, γ-2 herpesviruses effectively antagonize host immune responses through various mechanisms. The goal of this study is to better understand how γ-2 herpesviruses evade host PCD-mediated innate immunity, with a specific focus on the viral FLICE-like inhibitor protein (FLIP), designated as vFLIP. The main hypothesis of this grant is: a novel viral immune evasion and pathogenic strategy wherein vFLIP targets NF-κB, apoptosis, and autophagy to escape host PCD-mediated innate immunity and tumor suppression, ultimately contributing to the persistence and/or pathogenesis of γ-2 herpesviruses. PUBLIC HEALTH RELEVANCE: To endure in hosts through their ability to establish a life-long persistent infection often associated with pathogenesis, γ-2 herpesviruses effectively antagonize host immune responses through various mechanisms. The goal of this study is to better understand how γ-2 herpesviruses evade host programmed cell death-mediated innate immunity, with a specific focus on the viral FLICE-like inhibitor protein (FLIP), designated as vFLIP.

Public health relevance
Project Narrative To endure in hosts through their ability to establish a life-long persistent infection often associated with pathogenesis, γ-2 herpesviruses effectively antagonize host immune responses through various mechanisms. The goal of this study is to better understand how γ-2 herpesviruses evade host programmed cell death-mediated innate immunity, with a specific focus on the viral FLICE-like inhibitor protein (FLIP), designated as vFLIP.